Extracellular vesicles, meth relapse and sex differences

Abstract
The overarching goal of this proposal is to examine the role of EVs in the damaging effects of meth between the
sexes using drug triggered reinstatement (relapse) of extinguished intravenous meth self-administration in rats.
Based on the reduced efficacy of Ibudilast to attenuate meth relapse in female rats (see research strategy),
Adrian will now: 1) Evaluate if the EV size and numbers are more exacerbated in female rats and 2) If the EV
proteome is more impacted in females compared to male rats. These include identification and validation of
distinct sex specific EV markers followed by their validation in blood plasma. Successful completion of the tasks
proposed in this diversity supplement will hone Adrian's unique ability gain good knowledge in the area of
neurobiology of drug addiction and shall position him strong foundation for his future postdoctoral research.

Public health relevance
Project Narrative Based on the reduced efficacy of Ibudilast to attenuate meth relapse in female rats, the goals in this diversity supplement will 1) Evaluate if the EV size and numbers are more exacerbated in female rats and 2) If the EV proteome is more impacted in females compared to male rats. These include identification and validation of distinct sex specific EV markers followed by their validation in blood plasma.